Aerodynamic measurements in the pediatric population

ABSTRACT
Voice disorders affect approximately one million American children and the associated impacts on quality of
life are significant. These disorders often go underdiagnosed and undertreated in children due to subjective,
imprecise evaluation methods, and the misconception that children do not experience a change in voice-related
quality of life. The ability to perform at school, relate to friends and family, participate in social activities, or engage
in everyday activities can be severely affected by voice impairment. A key part of providing voice care is a
complete voice assessment, including aerodynamic evaluation of vocal input. The primary goals of this proposal
are to develop noninvasive aerodynamic assessments which are reliable in the pediatric population, and to
describe differences between healthy and dysphonic pediatric voices between the ages of 4-17 years.
Three methods of aerodynamic measurement have been developed in our laboratory: complete airflow
interruption; incomplete airflow interruption; and airflow redirection. These methods have been validated and
shown to be accurate with adults. We have demonstrated improved measurement reliability for aerodynamic
parameters using complete airflow interruption in children. Additional modifications must be made to optimize
assessment and address anatomic and physiological differences between adults and children. We will adjust our
current protocols with shorter trial times, auditory masking, visual feedback in the form of gamification, and cheek
restraints. These modifications will allow for more reliable measurement of aerodynamic parameters in children.
Aerodynamic evaluation will be performed in children with normal voice and children with voice disorders
related to vocal fold nodules or polyp. Aerodynamic parameters will be correlated with pediatric voice-related
quality of life score, lesion characteristics, clinician-based perceptual voice assessment, and acoustic voice
assessment.
This research will optimize a reliable method of aerodynamic voice assessment in children, determine how
aerodynamic input differs in the setting of a voice disorder and how that correlates with other voice measures,
and generate normative data ranges for aerodynamic parameters measured by mechanical interruption.
Complete assessment of pediatric voice has been limited by patient-controlled methods of aerodynamic
measurement, which are not well-suited to children. This research represents a shift in pediatric voice evaluation
and provides a foundation for complete, objective, reliable voice assessment in children.

Public health relevance
PROJECT NARRATIVE Voice disorders in children are common. Critical to comprehensive voice care is providing a complete voice assessment, and our ability to do that in children is limited by unreliable methods of measuring aerodynamic input to voice production. This research will develop an optimized method of aerodynamic voice assessment in children and apply that method to children with and without voice disorders, generating valuable methodology and information that can improve the way we care for children with voice impairment.